Administrative Supplement: Resource for Macromolecular Modeling and Visualization

The proposal proposes additional funds to be specifically used in support of the “Hands-on
Workshop” series offered by the NIH Resource for Macromolecular Modeling and Visualization.
These include 1) laptop computers for use by the participants during the workshops; 2)
Compute nodes to be used by the participants during and after the workshops; and 3) Storage
needed for the files produced by the simulations performed by the participants.

Public health relevance
Workshops in computational biophysics train biomedical researchers, including graduate students, postdoctoral associates, and faculty members, as well as scientists from industry how to include modeling and simulation methods in their research.